Interferon-beta trans-signaling in transplant

Project Summary
Transplantation is the ideal treatment for end-stage organ failure, but graft survival is suboptimal, with an average
half-life of ~10-15 years for most organs. Ischemia-reperfusion injury (IRI), which is proportional to the organ's
cold ischemia storage (CIS) time, contributes to delayed graft function and constitutes a major risk factor for
early allograft loss. IRI activates the production of a network of interactive pro-inflammatory cytokines, including
(IL-6), that promote donor-reactive effector (Teff) and memory (Tmem) T cells and reduce regulatory T cells
(Treg). Understanding the physiological mechanisms that counteract this inflammation has the potential to
identify new therapeutic targets in transplant.
During this proposal's first cycle, we predicted, using an in silico computational model, an unanticipated
Treg-enhancing effect of the pro-inflammatory cytokine interferon-beta (IFN), a type I interferon. We tested this
prediction experimentally and demonstrated that, in stark contradiction with its pro-inflammatory physiological
role IRI in transplant, exogenous interferon-beta (IFN) synergizes with CTLA-4 Ig to prolong allograft survival
by directly acting on T cells to enhance Treg induction through the increase of Foxp3 acetylation. Herein we
propose to build upon these findings and study a previously-unrecognized mode of type I IFN signaling (trans-
signaling) involving a soluble isoform of the interferon receptor 2 subunit (sIFNAR2), which we contend is
required for the immunosuppressive effects of IFN in transplant. We have obtained solid preliminary data
supporting the hypothesis that (i) sIFNAR2 is produced in response to IRI-induced pro-inflammatory cytokines,
including IL-6, (ii) sIFNAR2 builds up and over time shifts the IFN response on T cells from inflammatory to
immunosuppressive, and (iii) this is achieved mechanistically through IFN/sIFNAR2 trans-signaling which
increases Treg induction and decreases Teff proliferation. We also contend that early exogenous administration
of sIFNAR2 together with IFN post-transplant can counteract the Treg-depleting effect of pro-inflammatory
cytokines produced in IRI to prolong allograft survival. We will test this hypothesis using an integrated
computational and experimental approach, which accelerates research and minimizes the number of
experiments in animals through the following specific aims. We will demonstrate that IFN/sIFNAR2 trans-
signaling is required for IFN to increase Treg and decrease Teff responses in vivo in the context of transplant
(Aim 1), we will elucidate the molecular mechanisms responsible for IFN/sIFNAR2 trans-signaling effects on T
cell responses and innate antiviral responses (Aim 2), and we will establish the role of sIFNAR2 in controlling
the pro-inflammatory/immunosuppressive balance in T cell responses during ischemia-reperfusion injury (IRI) in
murine transplant models (Aim 3).

Public health relevance
PROJECT NARRATIVE These studies seek to understand the cellular and molecular mechanisms through which interferon-beta (IFN) trans-signaling, a previously undescribed signaling mode, can balance effector and immunosuppressive alloimmune responses during ischemia-reperfusion injury in transplant and be used to prolong allograft survival. The studies will employ multiple mouse models, human and murine in vitro experimental systems, computational models, as well as strategies to track the soluble receptor required for trans-signaling, to elucidate these mechanisms. This project has implications for identifying a novel promising therapeutic approach for improving transplant graft survival and elucidating fundamental mechanisms that shape immune responses in autoimmune disease and cancer. 1